Extracellular RNA biomarkers of myotonic dystrophy type 1

Summary
Myotonic dystrophy (dystrophia myotonica; DM) is an inherited disorder that causes progressive muscle
weakness and wasting. No effective treatments are available to slow or reverse symptoms. The mutation
responsible for DM type 1 (DM1) is an expanded CTG repeat in the DM protein kinase (DMPK) gene. Clinical
symptoms result from pathogenic effects of the DMPK mRNA that lead to mis-regulation of alternative pre-
mRNA splicing of at least several dozen transcripts. Monitoring of a panel of RNA splicing outcomes in
repeated muscle tissue biopsies has been proposed to measure DM1 disease activity during future clinical
trials. However, the muscle biopsy procedure is invasive, painful, impractical for long-term monitoring, and in
pediatric patients requires general anesthesia, which increases risk. Extracellular RNA (exRNA) refers to
mRNAs and noncoding RNAs that are released from and taken up by cells as a novel form of cell-to-cell
communication. exRNAs in blood and urine serve as genetic biomarkers of cancers and other disease states.
Recent work has suggested that splicing outcomes in urine exRNA may have the capacity to serve as robust
monitoring biomarkers of DM1. This prospective multi-center study will test the hypothesis that exRNA contains
a representative transcriptome that is altered in DM and is quantifiable in urine. Splicing outcomes in urine
exRNA are expected to correlate with DM1 disease severity using clinical measures of muscle function. R61
phase (Years 1 - 3): Aim 1 will identify and characterize the urine exRNA profile in DM1 patients and
unaffected control subjects. Droplet digital PCR (ddPCR), a state-of-the-art technology, will be used to
quantitate a panel of urine exRNA splice events previously reported as altered in DM1. Go/no-go milestone:
candidate exRNA biomarkers show differential splicing in DM1 vs. unaffected controls with a P value < 0.01.
Aim 2 will determine the feasibility and reliability of the exRNA splicing profile measured by ddPCR as useful
biomarkers of disease severity in DM1 patients using repeated measurements over two years. Go/no-go
milestone: candidate exRNA biomarkers demonstrate correlation of at least 0.45 with one or more measures of
muscle function and a false discovery rate of 5%. R33 phase (Years 4 - 5): Aim 3 will evaluate the optimal
exRNA biomarker candidate identified in the R61 phase as a predictor of DM1 disease status by longitudinal
monitoring of ddPCR splice events and clinical measurements of muscle function in a prospective cohort of
DM1 patients, and comparison of splice events in exRNA with those in muscle biopsy tissue. Proposed context
of use (COU): monitoring biomarker for serial assessment of disease status or burden in patients with DM1.
The approach used in this proposal also will be applicable to DM type 2 (DM2), a range of muscular
dystrophies, and other genetic disorders.

Public health relevance
Project narrative (public health relevance statement) Myotonic dystrophy is an inherited disorder that causes progressive muscle weakness and wasting. There is no cure. The purpose of this proposal is to develop novel strategies that will accelerate the discovery of effective treatments.